Training in Trauma and Sepsis Research

Trauma and sepsis are among the most important causes of morbidity and mortality in humans.
The Pitt Trauma Research Training Program (Pitt TRTP) is focused on the training of physician-
scientists and a few full-time PhDs in trauma, sepsis, and related pathobiological process including
wound repair and tissue engineering. Progress in complex clinical fields such as trauma and
sepsis requires investigative teams collectively possessing skills in diverse areas of research.
These specialized research areas span the rapidly advancing disciplines within clinical and basic
research and thus, require scientists capable of managing and evaluating high dimensional data
sets, other scientists facile skilled in reverse translating clinical observations into relevant
preclinical models (both small and large animals), and finally, investigators well-versed in the
design and execution of clinical trials and assessing optimal strategies to improve outcomes in
acutely ill trauma/surgical patients. To address these inter- and multidisciplinary needs, we have
organized the Pitt TRTP around two broad tracks: 1) the Clinical Research Track; and 2) the
Basic Research Track. Track Oversight Committees (TOC) with demonstrated expertise oversee
each track, which in turn consists of expert faculty fully engaged with the program. These
investigators have worked together for many years in collaborative, multidisciplinary teams.
Customized training plans are developed for each trainee and approved by the TOCs. The Pitt
TRTP leverages extensive local resources at the University of Pittsburgh School of Medicine,
including robust clinical and research programs in trauma, acute care surgery, Surgical Critical
Care, and sepsis research; world-class clinical programs (from which the patient data and
biobanks are procured), including three Level Trauma Centers which admit over 8,000 trauma and
4000 acute care surgery patients per year as well as carrying out multiple clinical trials in the
setting of trauma and sepsis; collaborating departments with international expertise in
computational and systems biology along with immunology; and extensive core facilities which
support current- and next-generation “omics” research.

Public health relevance
PROJECT NARRATIVE Trauma and sepsis are among the leading causes of death and morbidity worldwide. We propose to train surgeon-scientists uniquely prepared to identify and address the most pressing questions limiting progress in the management of trauma and sepsis patients.